IDENTIFICATION OF PROTEIN COMPONENTS INVOLVED IN PLANT ORGANOGENESIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Proteins important for Arabidopsis organogenesis tend to form complexes. We use immuno pull-down approaches to partially purify the complexes and use mass spectrometry to identify the components in the complexes. This work will greatly facilitate the discovery of the mechanisms responsible for plant organogenesis.